The Epigenetic Regulator Prdm16 Controls Smooth Muscle Phenotypic Modulation and Atherosclerosis Risk

PROJECT ABSTRACT
Coronary artery disease (CAD) is the worldwide leading cause of death, highlighting a critical need for
additional therapies beyond what is currently available. Furthermore, the dramatic rise in obesity and type 2
diabetes (T2D) threatens to derail progress in treatment of CAD over the last 50 years. Obesity causes insulin
resistance, which increases the risk of CAD both directly and indirectly, through the development of T2D and
through the associated abnormalities of the metabolic syndrome – dyslipidemia, hypertension, high waist-hip
ratio, and elevated glucose. There are few treatments available for insulin resistance and metabolic syndrome
despite affecting nearly 30% of the US. Additionally, despite discovery of >200 genetic loci associated with
CAD and >320 loci associated with insulin resistance related metabolic traits, the translation of these genetic
insights into genetically driven therapies has been stagnated by the lack of understanding of the mechanistic
connection between of CAD and insulin resistance. This proposal aims to determine the mechanistic
connection of the gene PRDM16 (PR domain containing 16), which is associated with both CAD and insulin
resistance related metabolic traits, to atherosclerosis. PRDM16 is known to regulate insulin resistance through
regulation of brown and beige adipose tissue function. However, the role of PRDM16 in atherosclerosis is
unknown. PRDM16 is a promising causal gene in CAD due to its high expression in vascular tissues and
smooth muscle cells (SMCs); its high correlation with markers of SMC function; its interaction with other known
CAD loci; and its interaction with important CAD signaling pathways. The applicant’s central hypothesis is
that PRDM16 promotes CAD risk through epigenetic regulation of gene networks that modulate SMC
phenotype to promote atherosclerosis risk. The applicant’s primary sponsor, Dr. Tom Quertermous, has
developed a paradigm of SMC phenotypic modulation whereby SMCs de-differentiate, proliferate and migrate
in response to atherogenic stimuli. This paradigm was developed using high resolution single cell sequencing
technologies. Leveraging this platform, the application will test their hypothesis through two proposed aims. In
Aim 1, the applicant will determine the impact of Prdm16 on vascular SMC function in atherosclerosis. In Aim
2, the applicant will determine the impact of Prdm16 on SMC phenotypic modulation using single cell
sequencing technologies. The applicant will test these aims using a novel mouse model whereby Prdm16 is
deleted from SMCs as well as by using molecular perturbations of PRDM16 in complementary in-vitro
approaches. The proposed work will discover the causal role of PRDM16 in atherosclerosis and the
fundamental role of PRDM16 in vascular SMC biology. Additionally, this work will identify a novel pathway
connecting both CAD and insulin resistance, which will lay the foundation for discovery of novel therapies that
may treat both CAD and insulin resistance.

Public health relevance
PROJECT NARRATIVE Although hundreds of genes have been associated with coronary artery disease (CAD) and insulin resistance related metabolic traits, the lack of mechanisms linking CAD to insulin resistance has hampered development of new therapies. This study will determine the role of the gene PRDM16 (PR domain containing 16), which is at the intersection of both CAD and insulin resistance, on smooth muscle cell function and atherosclerosis using novel conditional knockout mouse models in conjunction with cutting edge genomic sequencing approaches. By determining the role of PRDM16 in smooth muscle cell function and atherosclerosis, this work will not only determine the mechanistic connection between PRDM16 and CAD but will also identify novel mechanistic connections between CAD and insulin resistance.